Tumor heterogeneity in liver cancer

The spatial cellular context plays a pivotal role in shaping intratumor heterogeneity. However, understanding how each tumor establishes its unique spatial landscape and what factors drive the landscape for tumor fitness remains significantly challenging. In the project, we performed single-cell spatial omics profiling of tumor biopsies from liver cancer patients. We developed deep learning-based approaches to systematically decode the heterogeneous spatial architectures of tumors and investigate their relationship with tumor aggressiveness.